Cancer Center Support Grant

OVERALL
PROJECT SUMMARY/ABSTRACT!
Now in its 43rd year as an NCI-Designated Comprehensive Cancer Center, Yale Cancer Center (YCC) has
established a strong tradition of high-impact cancer research and a deep culture of communication and
collaboration that unites 286 basic, translational, population, and clinical scientists representing all biomedical
disciplines. YCC arms these investigators with a suite of enabling cores and powerful collaborative
opportunities and resources. Through intra- and inter-programmatic collaboration, the overarching goals of
YCC are to understand and prevent cancer, detect cancer early, and manage cancer treatment more
accurately and effectively. The seven Research Programs are the heart of YCC, and each program is led by a
basic scientist in partnership with a clinical/translational scientist to foster transdisciplinary research and the
advancement of Yale science from the bench to the clinic. In addition, YCC supports and manages Shared
Resources that provide unique expertise and enabling technologies that enrich the scope and expedite
progress of each Research Program. YCC infrastructure further enables ground-breaking clinical trials that
capitalize on Yale science and incorporate novel designs and biomarker assessments to optimize patient
selection, define treatment resistance, and inform new therapeutic approaches. Overall cancer funding (direct
costs) has increased 51% from $58.2M in 2012 to $88M in 2017, including an increase from $17.8M to $23.5M
in NCI funding (direct costs). YCC holds two NCI SPORE grants, a UM1, U10, multiple P01s, numerous multi-
investigator R01 grants, and leadership in two SU2C Dream Team awards. Additionally, during the current
funding cycle, YCC leveraged $5.9M, reflecting CCSG Developmental Funds and institutional support, to
advance new research and collaborations, resulting in $55.6M in new extramural funding - a 9-fold return on
investment. During the same period, accrual to interventional treatment trials increased 82%, from 471 to 859,
and accruals to early-phase treatment trials (pilot, I, I-II) increased three-fold, now representing 44% of total
treatment accruals. No less important, YCC has expanded and invested in initiatives and research that seeks
to impact cancer inequities and the needs of our catchment area at an individual, institutional, and policy level.
Over the next five years, YCC will continue to develop initiatives and resources to foster innovation,
collaboration, excellence and synergy to maximize the impact of Yale’s talent and expertise on the
understanding, prevention and treatment of cancer.!

Public health relevance
OVERALL PROJECT NARRATIVE The overarching mission of Yale Cancer Center (YCC) is to understand and prevent cancer, detect cancer early, and manage more accurately and effectively cancer treatment. YCC is committed to fulfilling these goals by supporting collaborative research and education activities aimed at delivering the highest quality patient- centered care, achieving breakthrough discoveries, and training future leaders in cancer science and medicine. !